VRC: Develop regenerative therapies for neurological vision loss

Abstract
We propose to promote long-distance axon regeneration of injured optic nerve or tract and recovery of
visual function in adult mammals by enhancing intrinsic growth capacity and growth cone dynamics of mature
neurons. We will study whether inhibiting let-7 and/or upregulating its suppressors lin28 and lin41 in retinal
cells promotes robust axon regeneration and functional recovery in adult mammals with optic axon injury. We
will also study whether upregulating cytoskeletal TACC3 protein stimulates dramatic axon regeneration by
targeting growth cones directly. CNS neurons lose the ability to regenerate axons with age, and this limits
functional recovery after injury. Many genes have been identified to control the growth ability of mature
neurons, but none have been translated to clinical use. The best targets are probably those with the potential
to impact multiple genes simultaneously. Among them, let-7 miRNA seems important for regulating age-
dependent decline in axon regeneration. We propose to enhance the growth capacity of mature neurons by
targeting the lin28/let-7/lin41 pathway. Because dystrophic growth cones in axotomized CNS contribute to
axon regeneration failure, we also propose to enhance cytoskeletal growth dynamics by upregulating the
TACC3 gene. We hypothesize that the let-7 pathway regulates axon regeneration in mammalians and that
targeting this pathway plus the cytoskeletal TACC3 gene stimulates robust axon regeneration and functional
recovery of visual pathways. Using the novel AAV vectors developed in the PI’s lab, we will determine
whether inhibiting let-7 and/or upregulating lin28, lin41, or TACC3 in retinal cells promotes robust axon
regeneration and functional recovery in adult rodents with optic nerve or tract injury. Aim 1 proposes to study
whether intravitreal injections of the individual or combined viral vectors for let-7 inhibitor, lin28, or lin41
enhance optic axon regeneration, retinal ganglion cells survival, and functional recovery in adult mice. In Aim
2, we will use our AAV vectors to study whether upregulating TACC3 stimulates dramatic axon regeneration
and whether combination therapies targeting both let-7 and TACC3 signals yield better axon regeneration and
functional recovery in adult rodents with optic axon injury than either individual approach. Use of our unique
viral vectors has the potential not only to provide important new insights into the molecular control of growth in
mature CNS neurons, but also to develop practical and effective strategies to promote axon regeneration and
functional recovery in mammals. Our experiments with combined strategies to target both somatic neuronal
program and growth cone cytoskeletal dynamics should stimulate further axon regeneration and functional
recovery. We thus anticipate identifying extremely promising regenerative strategies in adult mammals. Our
viral vectors, which are administered post-injury, can be applied to multiple axon tracts and readily translated
into clinical trials. The success of this project may reverse the visual functional deficits, improve the quality of
life in many patients, and reduce the financial burdens to patients, families, and the public.

Public health relevance
Narrative We aim to promote long-distance regeneration of injured optic axons and recovery of visual function in adult mammals using the unique AAV vectors that inhibit let-7 signals and upregulate cytoskeletal TACC3 protein. The success of this project may develop highly successful regenerative-based therapies for patients with neurogenic vision loss.